Longitudinal examination of emotional reactivity and reactive aggression linking threat exposure with childhood self-injurious thoughts and behaviors

PROJECT SUMMARY/ABSTRACT
Despite misconceptions that young children do not experience self-injurious thoughts and behaviors (STBs),
data from samples of youth that include children under age 9 suggest rates of suicidal ideation between
11%–19%, non-suicidal self-injury at 6.2%–21%, and suicide attempts between 2.4%–3.5%. Although rare,
rates of suicide death in young children are increasing. However, the development of STBs in young children
is vastly understudied. Our team’s research demonstrates a robust link between threat exposure history and
risk for STBs in youth. Moreover, data support that threat experiences increase risk for STBs possibly
through heightened emotional reactivity and reactive aggression. Much of the work examining the impact of
threat exposure on the development of STBs focuses on adolescent youth, long after many children have
experienced threat and after STBs have developed for some youth. The purpose of the current study is to
test key components of our conceptual model positing that a history of exposure to threat initiates develop-
mental pathways toward earlier risk for STBs in young children through its influence on emotional reactivity
and reactive aggression. Moreover, youth may be at greatest risk for STBs in the days after future threat and
non-threat negative events occur, highlighting the need to understand potential short-term risk (i.e., over
days) for STBs among young children. Aim 1 of this proposal will investigate the extent to which more severe
and multiple threat exposures contribute to earlier emergence of STBs in young children ages 5–9. Aim 2 will
examine emotional reactivity and reactive aggression as predictors of STBs, including short-term (days) and
longer-term (months) predictors, and as mechanisms through which threat may influence STBs. Aim 3 will
examine the extent to which future threat and non-threat negative events amplify short- and long-term risk for
STBs among young children with emotional reactivity and reactive aggression. We will conduct exploratory
analyses testing our full model positing that threat influences STBs through heightened emotional reactivity
and reactive aggression, particularly when future threat or non-threat events occur. We will also explore sex
and race differences in STBs in young children. We will enroll 300 5- to 7-year-olds with a history of a range
of threat exposure and their caregiver in a racially diverse catchment area and follow youth longitudinally for
2 years (until ages 7–9). Youth and caregivers will complete an in-home baseline assessment composed of
multiple methods, including clinical interviews; questionnaires; and observational, physiological (i.e.,
respiratory sinus arrythmia), and behavioral measures within developmentally relevant negative emotional
contexts (e.g., social-evaluative stressor). Caregivers and youth will complete three 1-week periods of daily
diary assessments spaced 1 month apart to assess short-term STB risk. Remote follow-up assessments will
occur every 6 months to examine long-term STB risk. This project will have a high impact on the field by
examining early pathways to STB risk and identifying intervention points to offset negative trajectories.

Public health relevance
PROJECT NARRATIVE This research is one of the first steps to understanding how and when self-injurious thoughts and behaviors (STBs) emerge in young children during middle childhood. Findings will help identify potential risk factors and mechanisms that may serve as targets for preventing STBs earlier in development before the adolescent period. Findings will set the stage for future research studies aimed at carefully understanding developmental pathways toward STB risk from childhood through adolescence.